CORALE-SeroNet Project 1

ABSTRACT
Pressing questions pertain to the consistently observed paradoxes regarding the variable nature of host
susceptibility and response to SARS-CoV-2. We and others have reported on more active spread and greater
morbidity among older persons and ethnic/racial minorities, especially with certain comorbidities and metabolic.
To date the evidence to date suggests that while some individuals exhibit a particular vulnerability to SARS-CoV-
2 (i.e. susceptibility), many others have an intrinsic or acquired relative immunity (i.e. resistance) to infection
or disease risk or both for unknown reasons. Further compounding the enigmatic nature of SARS-CoV-2 risk is
the conflicting data on measures of immunity. We and others have found that the extent to which individuals
exhibit a post-infectious IgG antibody response to SARS-CoV-2 is highly variable – many persons have no
antibodies detected in the peripheral circulation within weeks to months following resolution of symptoms. We
hypothesize that: (H1) the natural history of response to SARS-CoV-2 exposure is marked by discernible patterns
of susceptibility vs resistance that vary by demographic, clinical, and host-environment factors; and, (H2)
divergent clinical trajectories are driven by underlying inter-individual differences in the complex immune-
inflammatory response to SARS-CoV-2 exposure. Based on early observations and emerging data, we anticipate
four potential clinical trajectories among exposed individuals: (i) those with exposure, but apparently no infection;
(ii) infection with minimal to no symptoms, then persistent immunity; (ii) infection with symptoms, recovery,
persistent immunity; and, (iv) infection, recovery, re-infection. To test these hypotheses, we propose to leverage
our existing CORALE study (n=10,370), a prospective longitudinal cohort study at a major metropolitan
healthcare system in Southern California. Our catchment area includes large numbers of Hispanic/LatinX, Black,
and Asian individuals across the age range, representing high-risk and understudied populations; in turn, our
health system is one of the nation’s highest volume centers for treating COVID-19 patients. Our specific aims
are to: (1) identify distinct trajectories and determinants of susceptibility and immunity to SARS-CoV-2; and (2)
identify distinct immune-inflammatory profiles (including bioactive lipid eicosanoids, acute phase proteins,
cytokines, and their derivatives) associated with susceptibility and immunity to SARS-CoV-2. We will use both
baseline measures and perform serial SARS-CoV-2 serologic measures (IgG + IgM) to longitudinally map
serologic response with clinical and functional measures and define specific trajectories of susceptibility vs
resistance (i.e. variations in degree of vulnerability to infection and illness, rate of recovery, and ability to maintain
durable clinical immunity to re-infection or co-infection by other viral illnesses such as influenza). Lastly, we will
examine heterogeneity in trajectories by sex, age, race/ethnicity, socioeconomic status, and host-environment
modifiers (e.g. smoking, diet, and other lifestyle/behavioral factors). This CORALE-SeroNet Project 1 will identify
the clinical and molecular profiles that signal robust immune reconstitution and functional recovery following
SARS-CoV-2 exposure in multiple diverse populations including understudied minorities.